Proof of concept studies for in vivo produced CAR-T cells that target B cell follicles as a treatment for HIV

ABSTRACT
MarPam Pharma is developing a chimeric antigen receptor (CAR)-T cell treatment that targets viral reservoirs
for durable remission of HIV without the need for antiretroviral therapies (ART). This treatment is an HIV-specific
CAR (specifically, CD4-MBL-CAR) T cell therapy that employs the CXCR5 chemokine receptor as a homing
device to direct anti-HIV killer T cells into “hidden” viral reservoirs in B cell follicles of secondary lymphoid tissue,
so that they can kill HIV-producing cells where the majority of viral replication occurs. Using the best in vivo
nonhuman primate (NHP) model of HIV, we developed CAR/CXCR5-T cells that show successful homing to B
cell follicles, evidence of direct contact with viral RNA+ infected cells, markedly decreased virus in B cell follicles,
and decreased viral loads in CAR/CXCR5-T cell treated ART-suppressed Simian immunodeficiency virus-
infected NHPs compared to controls. Our human CAR/CXCR5-T cells also show CXCR5-driven migratory and
anti-HIV killing characteristics in vitro, showing promise as a treatment for people living with HIV. FDA-approved
CAR-T cell therapies are successful in treating various cancers; however, the processes to produce the CAR-
T cells are complex, involving leukapheresis and ex-vivo manipulation of peripheral blood mononuclear cells
prior to reinfusion back to the patient. Thus, recent efforts are focused on developing universal, off-the-shelf in
vivo-produced CAR-T cell therapies, including the use of adeno-associated virus (AAV) gene delivery systems.
Since the process to produce an off-the-shelf AAV gene therapy is a fraction of the complexity of ex-vivo
production of CAR-T cells individualized for each patient, the expectation is that AAV gene therapy to produce
CAR/CXCR5-T cells will eventually prove to be less costly than current life-long therapy for HIV, which is
estimated at over $500,000. To develop an off-the-shelf in vivo CAR/CXCR5-T cell product, this proposal seeks
to perform the necessary first steps of producing receptor-targeted, AAV-directed CAR-T cells (second
generation [2G] -CAR/CXCR5-T cells) in vitro and assessing their targeted efficacy against HIV. Using our
intellectual property-protected technology to assemble AAV composites for receptor-targeted gene delivery, we
propose in vitro proof-of-concept studies to produce receptor-targeted, AAV-directed 2G-CAR/CXCR5-T cells
using AAV composites containing anti-CD5 monoclonal antibody (CD5mab) and carrying a 2G-CAR/CXCR5
DNA payload. As T cells specifically express CD5 on their cell surface, AAV-CD5mab composites carrying 2G-
CAR/CXCR5 DNA payload (AAV-CD5mab-2G-CAR/CXCR5) are expected to specifically bind CD5 on T cells
and transduce them, thereby producing functional 2G-CAR/CXCR5-T cells that home to B cell follicles in vivo.
Successful completion of the proposed studies will lay the groundwork not only for Phase II IND-enabling studies
for in vivo HIV 2G-CAR/CXCR5-T cells, but also for other therapeutic areas that could benefit from off-the-shelf
in vivo production of CAR-T cells.

Public health relevance
PROJECT NARRATIVE MarPam Pharma is developing a chimeric antigen receptor (CAR)-T cell treatment that targets HIV viral reservoirs for durable remission of HIV, thus addressing a critical unmet medical need for people living with HIV. To develop an in vivo produced CAR-T cell product, this proposal seeks to perform the necessary in vitro proof-of-concept studies of generating and assessing receptor-targeted, adeno-associated virus-directed production of CAR-T cells that kill HIV-producing cells in viral reservoirs. This study lays the groundwork not only for developing in vivo produced HIV CAR-T cell therapeutics, but also for other therapeutic areas that could benefit from in vivo production of CAR-T cells.